UW Core Center for Clinical Research of Musculoskeletal Conditions

The overall aim of our CCCR is to develop and provide scientifically rigorous, state-of-the-art methods
and resources for conducting musculoskeletal clinical research, thereby expanding the community of
investigators performing high-quality musculoskeletal clinical research and increasing the amount of
available useful data for researchers, clinicians, patients and policy makers. During the first funding cycle
for our CCCR, we successfully engaged with a large cohort of musculoskeletal clinical researchers, introducing
them to new methods and datasets. Through multiple projects focused on musculoskeletal conditions and
funded by a variety of entities (NIH, AHRQ and PCORI), our group at the University of Washington (UW) has
accumulated extensive experience and expertise performing large, clinical, effectiveness trials and
transforming routine clinical data into research-ready data. We have developed state-of-the-art methods and
accumulated a sizeable amount of cleaned, analyzable data to be used by musculoskeletal researchers.
Because of our expertise and resources, we are well-positioned to advance our UW Core Center for Clinical
Research (CCCR) in Musculoskeletal Diseases, the UW Clinical Learning, Evidence, And Research (CLEAR)
Center for Musculoskeletal Disorders. Our UW CCCR Specific Aims are: 1) Continue to improve methods
for clinical musculoskeletal studies, focusing on confirmatory learning methods (study design for both
observational studies and clinical trials) and predictive learning methods (artificial intelligence for
image processing and electronic health record [EHR] data, both structured and unstructured free text);
2) Continue a Resource Core that provides analysis-ready data sets and services for conducting
clinical musculoskeletal research; and 3) Continue an Administrative Core that provides overall
leadership for the CCCR, manages the financial aspects of the CCCR, provides communication and
outreach to musculoskeletal researchers, and evaluates the success of our efforts. By achieving these
aims, we will improve access to expertise and research-quality data, improve analytics by developing
methods and pipelines for the analysis of clinical data, and apply and disseminate knowledge regarding the
conduct of rigorous clinical trials. Our CCCR will be able to provide useful research data to health system
decision-makers who will then be able to apply the results of the research to real-world decisions. By achieving
these aims, we will facilitate the transition of health care delivery systems to true learning health care systems.
Finally, and importantly, we will work with training programs to train the next generation of investigators in the
methods and approaches outlined above.

Public health relevance
Our Core Center for Clinical Research will further the development of scientifically rigorous, state-of-the-art methods for clinical musculoskeletal research; provide resources for conducting such research; and expand the community of investigators performing high-quality clinical research. This will increase the quality and quantity of data useful to clinicians, patients and policy makers as well as facilitate the transformation of traditional health care systems into learning health care systems. The ultimate goal is improvement of the quality of care and health of the public.